BrainAware: Interactive digital psychoeducation for adolescents and young adults with substance use disorders

Project Summary/Abstract Treatment professionals struggle to get adolescents and young adults to engage and persist with treatment for substance abuse disorders. It is particularly difficult to maintain interest or enthusiasm with two core elements of evidence-based substance abuse treatment, psychoeducation and peer support. We propose to counter young people's resistance to treatment by creating an interactive educational app that is engaging, provides sound instruction, and facilitates peer interaction. Andamio Games is partnering with the Perelman School of Medicine's Center for Studies of Addiction at the University of Pennsylvania, a nationally recognized laboratory for research and development of new treatments for substance use disorders. We will design, develop, and test a learning game called BrainAware based on adapted content from the National Institute on Drug Abuse (NIDA), and supplemented with original curriculum on medication-assisted-treatment (MAT), to teach the neurobiology of addiction to adolescents and young adults in behavioral treatment. We will concurrently develop a dashboard companion app that will provide counselors with unique capabilities to effectively lead group psychoeducation sessions. With funding from a previous NIMH grant, Andamio has already tackled the problem of making neuroscience more engaging and easier to learn by developing the mobile educational app iNeuron and testing it with high school students. Our educational efficacy study of over 300 students in 20 classrooms demonstrated that using iNeuron resulted in larger concept knowledge gains relative to standard instruction. For this Fast-Track project we will build BrainAware on the foundation of iNeuron’s existing neural simulator and instructional design, and use our in-house app development toolkit. A key feature developed for iNeuron that will be adapted for BrainAware is collaborative play, where peers must together across devices to solve problems. BrainAware’s counselor dashboard will be adapted from the one developed for iNeuron, allowing counselors to monitor and respond to individual and group activity in real time. We will design BrainAware in consultation with experts in the neurobiology of addiction, treatment counselors, and a youth/young adult community advisory board, then test BrainAware in an educational efficacy study with adolescents and young adults undergoing substance use disorder treatment. We will test the hypothesis that using BrainAware will result in larger gains in concept knowledge and increased engagement relative to learning with standard psychoeducation instructional methods. Upon successful completion of the study, the BrainAware app and dashboard will be marketed to over 15,000 treatment facilities through our commercial partner Hazelden Publishing. Our vision is to ultimately create a comprehensive, interactive digital curriculum for psychoeducation that can be utilized by adolescents and young adults with substance use disorders to positively impact broader treatment outcomes.

Public health relevance
Project Narrative A particular challenge to the field of substance use disorder treatment is the engagement of young adults (aged 18-25) and adolescents (aged 12-17), who resist treatment based on multiple factors specific to their age group. Andamio Games, in partnership with the Center for Studies of Addiction at the University of Pennsylvania, proposes to develop and implement an interactive, collaborative digital learning app and counselor dashboard app for use in adolescent and young adult substance abuse treatment to provide education on the neurobiology of addiction. Our longer-term goal is to utilize our unique educational technology platform to improve the delivery and effectiveness of a broad range of psychoeducational curriculum for this challenging cohort.